PTCA III--MULTIDEVICE REGISTRY

To prospectively evaluate the safety and efficacy of several new interventional devices currently applied to patient care, the New Approaches to Coronary Intervention (NACI) Registry was established. Thirty-nine centers including the major users of new coronary interventional devices currently provide data for consecutively treated patients. We seek support to extend the NACI Registry by three years, in order to: . To complete recruitment and follow-up of patients treated with one of the seven devices which are currently included in the Registry. . To carry out detailed evaluation for each interventional device overall, by gender and by other meaningful subgroups: de novo lesion, restenotic lesion, vein graft disease, etc. . To perform carefully conceived comparisons of devices in controlled well-defined subgroups. . To work with investigators on reporting results in a timely manner. We expect that when our proposed investigation is completed, it will have a major clinical and economic benefit to all sectors in the field of interventional cardiology.